Empowering Data Science research and training for RCMI researchers and students

PROJECT SUMMARY
This proposal is a supplement to our existing Ola Hawaii grant, building upon the foundational
work previously established under this award. Recent advancements in biomedical and health
science underscore the important role of data science in deciphering complex health
phenomena, facilitating access to vast datasets and uncovering underlying patterns. However,
this progress also necessitates a concerted effort to bolster institutional capacity in data science
to fully harness its potential. The proposed data science supplement aims to strengthen
research capacity and cultivate expertise in Hawaii's biomedical and health sciences sector.
Aligned with Ola HAWAII's mission, our supplement focuses on RCMI-related projects to boost
their impact on health disparities research. By integrating data science into these projects, we
aim to gain insights into the health challenges faced by Hawaii's diverse populations. This
approach leverages the RCMI network to enhance research outcomes and understanding of
health disparities. In addition to supporting ongoing research, we also seek to nurture future
talent through educational and training programs with more advanced topics in data science.
These efforts will include developing a comprehensive curriculum, organizing workshops,
summer bootcamps, and inviting external experts to share insights with our research
community. These training programs are continuous efforts based on our experiences and will
cover more diverse and advanced data science topics, such as programming basics, omics data
analysis, cloud computing, artificial intelligence, statistical inference, and data ethics. In
summary, the proposed data science supplement represents a strategic effort to enhance
research capacity, address health disparities, and foster data science expertise in Hawaii's
biomedical landscape. By integrating data science support, education, and collaboration, we
aim to empower researchers, drive innovation, and make significant progress in understanding
and addressing health challenges in the state of Hawaii and beyond.

Public health relevance
PROJECT NARRATIVE Our supplement revitalizes Hawaii's biomedical research by embedding data science into projects from RCMI and their collaborators, targeting local health disparities. Introducing a specialized curriculum, workshops, and summer bootcamp, we aim to empower RCMI students and researchers with advanced tools, such as cloud computing, fostering innovation and collaborative research. This effort aligns with our dedication to diversity, ensuring broad access to data science training and creating impactful health solutions for Hawaii's underserved communities, thereby enhancing research capacity and health equity statewide and beyond.